Optimizing Strongyloides Testing in an At-Risk US Population

PROJECT SUMMARY
Strongyloidiasis, caused by infection with the parasitic nematode Strongyloides stercoralis, remains an
important public health problem in tropical and sub-tropical regions, with an estimated 30-100 million infected
persons globally. Because S. stercoralis infection is acquired from contact with contaminated soil, those most
at risk include the socioeconomically disadvantaged, those with agricultural occupations, and those living in
areas with poor sewage control practices. S. stercoralis larval migration during chronic infection is limited to the
gastrointestinal tract and lungs and causes few if any symptoms. However, larvae can disseminate and cause
severe disease in immunosuppressed individuals. The importance of identifying S. stercoralis infection before
immunosuppressive treatments are started has been highlighted by increased use of corticosteroids during the
COVID-19 pandemic and related increases in disseminated strongyloidiasis diagnoses. Because disseminated
strongyloidiasis is often diagnosed late, after larvae have caused significant and irreversible end-organ
damage, the mortality rate of disseminated strongyloidiasis is near 90%.
Regional studies and case reports indicate that strongyloidiasis is commonly diagnosed in tropical and sub-
tropical regions of the US. We have found 4-10% seropositivity in a Houston solid organ transplant cohort and,
more recently, even higher seropositivity (16.5%) in a central Texas community. Other small studies of US
immigrants from low- and middle-income countries have indicated infection rates as high as 46.1%.
Screening for strongyloidiasis is suboptimal due to poor knowledge of the disease among US healthcare
providers and imperfect performance of available diagnostic tests. The clinical gold standard of strongyloidiasis
diagnosis is microscopic evaluation of multiple stool specimens for S. stercoralis larva. Unfortunately, it is
challenging for patients to submit even one stool specimen in a timely manner, and US clinical laboratory
technicians may not have enough training and expertise to reliably identify larvae. Several serologic tests have
been developed, but commercially available tests have imperfect test performance and are less sensitive in
immunocompromised individuals who may not be able to mount a reliable humoral immune response. Newer
serologic and molecular tests based on recombinant antigens have been developed but are not yet
commercially available.
We propose a prospective study of adult HHS patients undergoing a panel of parasitologic, serologic, and
molecular Strongyloides assays, with the following specific aims: (1) to identify a high-performing
strongyloidiasis screening strategy for at-risk individuals living in the US and (2) to evaluate each assay as a
test-of-cure for strongyloidiasis. Improvement in Strongyloides testing would improve screening and
management practices, thereby allowing for timely treatment and reduction of strongyloidiasis related
morbidity.

Public health relevance
PROJECT NARRATIVE Due to its autoinfection cycle, Strongyloides stercoralis is one of the few helminths that can cause long standing disease even in infected persons who have departed areas of high endemicity. While strongyloidiasis typically causes few symptoms in immunocompetent persons, if an infected person develops cellular immunocompromise, S. stercoralis can disseminate, leading to severe disease and often irreversible disability or death. This research will evaluate a panel of S. stercoralis tests with the goal of identifying (1) an effective, accurate, and low-cost screening strategy for at-risk US populations and (2) a test-of-cure that can be used to follow-up cases, thereby preventing potential future morbidity and mortality from disseminated strongyloidiasis.